The atomic basis of leukocyte adhesion receptor (CD11c/CD18) activation and antagonism in solution

PROJECT SUMMARY/ABSTRACT The leukocyte integrin αXβ2 (CD11c/CD18) is an important cell adhesion protein in inflammatory responses of dendritic and myeloid cells. αXβ2 binds to a broad range of ligands through a canonical G-nucleotide-binding domain or inserted (αI)-domain when regulating immune cell migration from vasculature to the site of inflammation. The isolated αI-domain crystal structures solved to date show that the αI-domain allosterically changes shape and matures from the closed/low affinity to open/high affinity state (inside-out signaling). It has yet to be determined how the allosteric site and ligand-binding region of the αI-domain couple and how small molecule antagonists inhibit ligand binding by disrupting allostery. These structural alterations of the αI-domain on the cell surface have been theorized to control the intracellular recruitment of adaptors that link to signal transduction pathways and cytoskeleton rearrangements and ultimately regulate immune cell emigration when integrins bind ligands on the cell membrane. This proposal builds on previous progress in determining crystal structures of intact ectodomain αXβ2 and αLβ2 and elucidating the roles of secondary structural motions with functional assays. These structures showed that the αI-domain on the intact integrin platform unprecedentedly undergoes a shape-shifting pathway of allosteric activation that differs from the laid-out αI-domain activation mechanism but correlates well with the limited number of NMR and MD studies. We hypothesize that the αI- domain samples into an ensemble of closed/low affinity state conformations and antagonist blocks ligand binding while stabilizing a limited ensemble of closed/low affinity conformations. An NMR strategy established in the laboratory will be employed to characterize in-solution dynamics of the αI-domain and further analyze the molecular basis of how an antagonist decouples the ligand affinity and allostery.

Public health relevance
PROJECT NARRATIVE Leukocyte integrin αXβ2 provides key cellular regulatory mechanism of immune cell migration in defense against infection and autoimmune dysregulations, thus αXβ2 antagonism is a proven modality for controlling inflammation in autoimmune diseases. However, specifically inhibiting integrin functions, such as affinity and allosteric signaling remains a paramount challenge. Characterization of dynamic properties of αX I-domain activation and antagonist-induced inhibition will define a new paradigm for αXβ2 antagonism studied under conditions that closely mimic the physiological environment and provide important insights into the integrin functions targeted for human clinical intervention.